Modulation of beta-cell PKA activity affects glucose homeostasis

DESCRIPTION (provided by applicant): Raising cyclic AMP (cAMP) in the islet β-cells shows considerable therapeutic potential in the treatment of type 2 diabetes mellitus (T2DM). Elevating cAMP potentiates glucose-stimulated insulin secretion, enhances insulin synthesis to maintain insulin stores and protects β-cell mass through effects upon β-cell proliferation and β-cell survival. The cAMP signal is transduced through two signaling molecules, the cAMP-dependent protein kinase (PKA) and EPAC. The aim of this project is to use in vivo mouse models that manipulate PKA activity to understand the physiological role of β-cell PKA activity. Mouse strains that express a Cre-Lox-dependent constitutively active PKA subunit (caPKA) and a dominant negative PKA subunit (dnPKA) will be crossed to a strain expressing the inducible Cre-recombinase specifically in the islet β-cells (MIP-CreER) to generate mice with increased β-cell PKA activity (β-caPKA) and inhibited β-cell PKA activity (β-dnPKA). Experiments controlled using littermate mice will address three specific aims: 1. Determine whether activation PKA in β-cells enhances insulin secretion & glucose clearance. 2. Determine whether reduced β-cell PKA activity decreases insulin secretion and β-cell mass. 3. Determine whether altering β-cell function affects glucose sensitivity. In aims 1 and 2 PKA activity will be altered by administering tamoxifen at 10 weeks of age and the mice characterized during the 11th week. Aim 3 is a longer term study, in which tamoxifen will be administered at 10 weeks of age and the development of insulin resistance followed, or insulin resistance will be established before tamoxifen is administered. In vivo and in vitro studies (using isolated islets) in aims 1 and 2, will determine how PKA activity affects insulin secretion, insulin synthesis and β-cell mass and the role that altered β-cell PKA activity plays in the response of insulin secretion to incretin hormones. Studies performed in aims 1 and 2 will also determine whether there are potential adverse consequences of activating β-cell PKA, such as increased risk of hypoglycemia, an impaired counter-regulatory response or an increased of unregulated β-cell mass expansion. Aims 1 and 2 will also explore the role of β-cell PKA activity in the mechanisms of action of incretin hormones to potentiate insulin secretion. In aim 3, mice will be fed a high fat diet or a standard chow control diet to determine the role of β-cell PKA activity in the progression to insulin resistance. These studies will determine whether increasing β-cell PKA activity can prevent and/or reverse insulin resistance and whether decreasing PKA activity reduced β-cell viability and/or function that leads to the development of T2DM. These experiments will test the novel hypothesis that alterations in β-cell function can be a major contributing factor to peripheral insulin sensitivity. Overall, these experiments will determine the role that PKA activity in islet β- cells play in regulating β-cell function and mass and the effects that this has upon whole body glucose disposal.

Public health relevance
PUBLIC HEALTH RELEVANCE: The cyclic AMP signaling pathway shows considerable potential in treating diabetes by preserving the ability of the beta-cells of the islets of Langerhans to secrete insulin and in patenting beta-cell mass. This project explores the physiological role of the main cAMP signaling molecule in β-cells PKA activity within the β-cells of the pancreatic islets of Langerhans. The project uses of novel reagents to study the physiological consequences of altering the activity of β-cell PKA. Manipulation of beta-cell PKA activity will provide greater understanding of the basic science behind the therapeutic potential of this signaling pathway. It will also reveal potential pitfalls of harnessing this pathway for the treatment of diabetes. The cyclic AMP signaling pathway shows considerable potential in treating diabetes by preserving the ability of the beta-cells of the islets of Langerhans to secrete insulin and in patenting beta-cell mass. This project explores the physiological role of the main cAMP signaling molecule in β-cells PKA activity within the β-cells of the pancreatic islets of Langerhans. The project uses of novel reagents to study the physiological consequences of altering the activity of β-cell PKA. Manipulation of beta-cell PKA activity will provide greater understanding of the basic science behind the therapeutic potential of this signaling pathway. It will also reveal potential pitfalls of harnessing this pathway for the treatment of diabetes. __SpecificAimsTextDelimiter__ 2. SPECIFIC AIMS Protein kinase A (PKA), also known as the cyclic AMP-dependent protein kinase, is major mediator of the effects of cyclic AMP (cAMP) in the β-cells of the pancreatic islets of Langerhans. There is currently considerable research and pharmaceutical industry interest in cAMP signaling in the β-cells, as it can enhance glucose-stimulated insulin secretion and protect β-cell mass. This is exciting as it shows that one signaling molecule can achieve the two most important aims in targeting the islet β-cells to treat type 2 diabetes mellitus (T2DM). Nevertheless, our knowledge of the downstream molecular effectors that transduce the cAMP signal in β-cells remains incomplete. Previous studies have demonstrated a critical role of this pathway in the regulation of stimulus-secretion coupling in β-cells in vitro, but little is known about the impact of β-cell PKA activity in vivo on β-cell function and mass, and upon whole animal glucose metabolism. Thus, this study will test the hypotheses that β-cell PKA activity regulates whole body glucose homeostasis through enhanced insulin secretion and β-cell mass protection. This project will use unique genetic approaches to manipulate PKA activity specifically in the islet β-cells. These novel transgenic mouse models that have been developed in my laboratory, in combination with physiological, imaging and biochemical approaches will be used to determine how insulin secretion and glucose clearance in vivo is altered by PKA activity. It is anticipated that these studies will provide exciting new information necessary for advancing our understanding of cAMP signaling in β-cell biology and novel insights into the contribution of this signaling pathway to defects in β-cell functional mass associated with T2DM. The specific aims of this study are: 1. Determine whether activation PKA in β-cells enhances insulin secretion & glucose clearance. Mice with PKA activity up-regulated at 10 weeks of age, solely in the islet β-cells, will be used to determine whether elevated PKA signaling enhances insulin secretion leading to improved glucose clearance. These experiments will determine the manner in which insulin secretion is altered in response to increased β- cell PKA, by examining whether the effects lie at the first or the second phase of insulin secretion, or both, and whether there is a change in the threshold of the secretory response to glucose. It will be determined how changes in insulin secretion in response to altered β-cell PKA activity affect glucose clearance. Insulin synthesis, β-cell proliferation and β-cell apoptosis will be measured to determine whether activated PKA signaling acts upon insulin stores and/or β-cell mass to affect the insulin secretory capacity. The possible risks associated with enhanced β-cell PKA signaling such as the depletion of insulin stores, unregulated expansion of β-cell mass or hypoglycemia due to poorly controlled insulin secretion will also be determined. The role of β- cell PKA activity in incretin potentiation of glucose-stimulated insulin secretion will also be determined. 2. Determine whether reduced β-cell PKA activity decreases insulin secretion and β-cell mass. Expression of a dominant negative PKA subunit specifically in islet β-cells at 10 weeks of age is predicted to reduce insulin secretion and impair glucose clearance. Experiments in this aim will determine the effects upon insulin secretion and the maintenance of β-cell mass. Preproinsulin mRNA levels, proinsulin synthesis rates and pancreatic insulin content will be measured to determine whether insulin stores are affected. These experiments will determine whether PKA activity is required for both phases of insulin secretion in vivo and for the maintenance of pancreatic insulin stores and β-cell mass. Further experiments will explore the role of β-cell PKA activity in mediating the effects of incretins upon insulin secretion. 3. Determine whether altering β-cell function affects glucose sensitivity. Aim 3 will exploit the unique nature of these mouse models to study novel concepts of the role of β-cell function in the development and treatment of insulin resistance. It is proposed that changes in glucose control subject peripheral insulin target tissues to an altered environment of glucose exposure that leads to a reduction in peripheral insulin sensitivity. Long term studies described in this aim will determine whether: ¿ altered β-cell PKA activity to affect glucose control affects peripheral insulin sensitivity; ¿ pre-existing insulin resistance can be reversed by activating PKA in the β-cells; ¿ pre-existing insulin resistance can be advanced to T2DM by reducing β-cell PKA activity; ¿ altered β-cell PKA activity is sustained or whether physiological compensation occurs; ¿ reducing β-cell PKA activity will affect β-cell viability leading to a loss of β-cell mass.